Utilization of JAK inhibitor therapy in a transplant model of STAT1 GOF disease

Project Abstract:
The number of patients worldwide with severe immune dysregulation associated with STAT1
gain of function (GOF) disease is increasing due to genetic testing and early identification.
There is moderate success with using Janus kinase inhibitors (JAKi)s in balancing immune cell
function. However, hematopoietic stem cell transplant (HSCT) outcomes are not favorable with
a high incidence of secondary graft failure. The utility of treatment with JAKi pre-transplant to
improve outcomes is not clearly established. The central hypothesis is that impaired cytokine
signaling leads to secondary graft failure in HSCT in STAT1GOF and this can be mitigated by
pre-transplant JAKi treatment. In the first aim, we will evaluate the efficacy of JAKi inhibition pre-
and post-transplant using a murine model of STAT1 GOF. We will treat STAT1 GOF recipient
animals with JAKi before or after transplantation with WT bone marrow. By comparing the
outcomes of those treated before versus after transplant we will identify effects of inflammation
in the radioresistant bone marrow milieu that may persist after transplant. In the second aim, we
will xenotransplant primary CD34+ cells from STAT1 GOF patients into NSG mice and study
whether JAKi therapies affects their radiosensitivity and mitigation of inflammation related
consequences. Single cell transcriptomics performed on these cells will be compared to
transcriptional changes induced by STAT1 signaling that are known to affect stem cell niche
localization, quiescence, cell division, and differentiation. These studies will reveal mechanisms
by which hematopoiesis is impaired in STAT1 GOF patients and may lead to discovery of critical
disease biomarkers or new avenues for therapy and improved transplant outcomes.

Public health relevance
Project Narrative Patients with Primary Immunodeficiency Diseases (PIDD) are at high risk for progression of disease, severe morbidity and mortality. While bone marrow transplant can be life- saving, high rates of transplant failure remain a challenge. Here we study the utility of novel treatment strategies to improve transplant outcomes in a rare PIDD (STAT1 gain of function (GOF) deficiency), with the goal of extending the lives of many patients with PIDD.